Innate Immune Control of Neurotransmission

Abstract
Neuroinvasive flavivirus infections, such as those caused by West Nile virus (WNV) and Zika virus (ZIKV), lead
to severe neurological damage due to aberrant synaptic activity and excitotoxicity. However, despite their
growing threat to public health, no approved vaccines or specific treatments for these infections exist. Emerging
evidence suggests that innate immune signaling within neurons can modulate neurotransmission, offering
potential avenues for neuroprotection. Our preliminary studies reveal that Receptor-interacting protein kinase 3
(RIPK3), an immune kinase traditionally associated with necroptotic cell death, plays an unexpected role in
preserving neuronal survival during flavivirus infection by suppressing excitatory neurotransmission. RIPK3
activation diminishes sensitivity to glutamatergic stimulation, reduces calcium influx through N-methyl-D-
aspartate receptors (NMDARs), and requires the activity of Ca²⁺/calmodulin-dependent protein kinase II alpha
(CaMKIIα). In this proposal, we hypothesize that RIPK3 suppresses excitatory neurotransmission through
modulation of synaptic phosphoprotein activity, promoting neuronal survival during viral encephalitis and
excitotoxic stress. To test this, we will pursue two specific aims: Aim 1 will define the mechanisms by which
RIPK3 controls neuronal excitability using chemogenetics, electrophysiology, and in vivo calcium imaging to
assess how RIPK3 activation impacts neuronal firing and synaptic function. Aim 2 will elucidate how RIPK3's
regulation of the phosphoproteome confers neuroprotection by identifying binding partners and mapping
phosphorylation events downstream of RIPK3 signaling, as well as evaluating the roles of the RIPK3 targets
CaMKIIα and calcineurin in neuroprotection. This research will advance our understanding of neuroimmune
regulation of neurotransmission, potentially uncovering new therapeutic targets for neuroinvasive viral infections
and providing fundamental new insights into the interplay between immune signaling and neuronal function.

Public health relevance
Narrative Our project proposes to study how a protein that is typically involved in cell death (RIPK3) instead serves a unique pro-survival function in neurons during flavivirus infection. We hypothesize that, following infection, RIPK3 decreases neuronal sensitivity to the neurotransmitter glutamate and, in doing so, prevents overexuberant activation and subsequent neuronal death. Our study thus aims to identify a new mechanism of neuroprotection during neuroinvasive viral infection.